Mapping the cell-type-specific molecular and genetic basis of lupus using single cell multiomics

Abstract
Systemic lupus erythematosus (SLE) is an autoimmune rheumatic disease with elevated prevalence in women
and individuals of Asian, African, and Hispanic ancestries. SLE patients present a broad range of symptoms
across multiple organ systems and differentially respond to treatments. Our central hypothesis is twofold: 1)
genetic drivers of SLE affect gene regulatory mechanisms in specific cell types and activation states, and 2)
cellular drivers responsible for disease initiation and exacerbation may exhibit transcriptional regulatory states
(e.g., epigenomic states) poised to respond to environmental disease triggers. To test this hypothesis, we will
use highly innovative multiplexed multimodal single-cell sequencing to map cell-type-specific epigenomic,
transcriptomic, and surface protein features that stratify patients. When integrated with SLE GWAS data, we will
further fine-map SLE-associated variants and annotate the cellular contexts by which associated variants act
through. Finally, utilizing a novel strategy to sequence capillary blood, we will characterize circulating immune
cells in SLE patients during flare, resolution, and response to discrete treatments.
3

Public health relevance
Narrative Systemic lupus erythematosus (SLE) is a chronic autoimmune disease with variable presentation of symptoms and inconsistent response to therapy. Here, we propose to use highly innovative single cell epigenomic, transcriptomic, and proteomic analyses to map the cell-type-specific molecular and genetic basis underlying SLE heterogeneity. We expect our findings to shed light on the pathogenic states in specific immune cell subsets stratifying SLE patients, which, in turn, will create new opportunities for therapies directed toward each specific patient subgroup. 2